LONGITUDINAL FOLLOW-UP OF INDIVIDUALS WITH OPIOID USE DISORDER (LFU-OUD). 09/01/2021 - 08/31/2026. N01DA-19-2250. TASK ORDER 75N95021F00007 (TO26).

LONGITUDINAL FOLLOW-UP OF INDIVIDUALS WITH OPIOID USE DISORDER (LFU-OUD)